Characterizing superior colliculus inputs to midbrain dopamine centers in cue learning

PROJECT SUMMARY
Animals exist in complex, sensory rich environments. Certain environmental stimuli (i.e. cues) predict
beneficial outcomes (i.e., rewards) that are crucial for survival. In order to appropriately respond to these
predictive stimuli, we must be able to discriminate these cues from other sensory input and learn the value of
the rewards they predict, during cue-reward learning. Understanding the neural circuits underlying these
processes is critical, as disordered sensory processing is a hallmark of several psychiatric diseases such as
ADHD and substance use disorders. Dopamine (DA) neurons in the ventral tegmental area (VTA) and substantia
nigra pars compacta (SNc) are critical in cue-reward learning, but it is not understood how these regions integrate
sensory information about cues to drive unique aspects of conditioned behavior. The superior colliculus (SC),
which receives input from the retina, has been shown to drive DA neuron activity in response to visual stimuli,
and disrupting the SC can prevent DA activity and conditioned responding to visual cues. The anatomy and
function of SC projections to the VTA/SNc in cue-reward learning is not known.
To address this gap in knowledge, I will characterize the anatomical and functional connectivity of
the SC to VTA/SNc circuit (Aim 1) and determine the contributions of SC projections during visual cue
learning (Aim 2). To study the topography of this circuit, I will trace distinct pathways from the SC to either the
VTA or SNc and determine the projection targets of the neurons that receive SC input. To determine the
functional connectivity of SC inputs onto the VTA and SNc, I will excite SC projections via optogenetics while
recording the activity of DA neurons in the VTA and SNc through in vivo fiber photometry. These studies will test
the hypothesis that the SC drives DA firing via medial to lateral connections on the VTA and SNc. I will also
measure and manipulate SC projection activity (using fiber photometry and optogenetics, respectively) during a
visual discrimination learning task, to test the hypothesis that SC projections to the DA midbrain augment
conditioned behaviors to predictive cues. These studies will reveal how the SC communicates with the VTA and
SNc, for fundamental insights into the circuit mechanisms of cue-reward learning.

Public health relevance
PROJECT NARRATIVE The basal ganglia, including dopamine neurons, are crucial for learning about stimuli that predict rewards (cues), but it is not understood how this system receives sensory information needed to guide cue-based learning. Here, I use new techniques for mapping and manipulating brain circuits to investigate the role of projections from the superior colliculus, an evolutionarily ancient visual structure, to the dopamine system in the transformation of sensation to action.